TRANScranial direct current stimulation for POst-stroke motor Recover - a phase II sTudy (TRANSPORT 2)

Stroke is a leading cause of disability, with motor deficit as the most common complication after stroke.
Recovery of motor function after a stroke has been primarily attributed to the structural and/or functional
degree of injury to the descending motor pathways. In addition, various forms of neuroplasticity also contribute
to the recovery process, including unmasking of pre-existing connections, the establishment of new synaptic
contacts through axonal sprouting, reorganization of peri-lesional and homologous contralesional regions, and
modulation of stroke-induced abnormal interhemispheric interactions.
Transcranial direct current stimulation (tDCS), a non-invasive brain stimulation technique, has been shown to
promote and enhance brain plasticity and to modulate the excitatory and inhibitory interhemispheric imbalance
that developed after a stroke. When combined with a peripheral rehabilitation therapy, tDCS can enhance
synaptic plasticity and motor skill acquisition/consolidation by increasing or modulating afferent inputs to the
cortex while concurrently receiving central stimulation. Furthermore, meta-analyses have demonstrated a
dose-response relationship between current density and motor impairment reduction. A recently published
phase I current escalation study has shown that up to 4mA is safe and tolerable for stroke patients. It is a
logical step to conduct a dose selection phase II study while continuing to monitor safety and tolerability issue.
Modified CIMT(mCIMT), a peripheral therapy, overcomes a learned non-use phenomenon in stroke patients.
The protocol is effective, standardized and quantifiable.
The primary aim of this proposal is to determine whether there is an overall treatment effect among the three
dosing groups (sham+mCIMT, 2 mA+mCIMT and 4 mA+mCIMT) immediately after 2-week intervention in the
Fugl-Myer Upper-Extremity Scale (a measure of motor impairment). Additional outcome measures include the
Wolf Motor Function Test Time Score (a measure of functional motor activity), and the Stroke Impact Scale
Hand Subscale (a measure of the quality of life). The sustained benefit is assessed at 1 month as well as 3
months post-intervention. Secondary aims will assess safety, tolerability, and feasibility to implement this
combined approach in a multi-site trial. An exploratory aim will examine whether weighted corticospinal tract-
lesion load (wCST-LL, structural assessment of integrity of descending motor tract) or Motor Evoked Potentials
(MEPs, functional assessment of integrity of descending motor tract) or a combination of both are correlated
with changes in FM-UE scale, and evaluate the utility of these measures as biomarkers for patient selection
criteria in future confirmatory Phase III study.

Public health relevance
The proposed research is relevant to public health because motor impairment is the most common complication after stroke and effective motor rehabilitation modalities are still lacking. Transcranial direct current stimulation (tDCS) is a promising non-invasive brain stimulation technique for stroke motor recovery. This multi-center phase II clinical trial aim to test where there is an overall treatment effect among three tDCS dosing groups (Sham, 2mA and 4mA), along with modified constraint-induced movement therapy, immediately after 2-week intervention as well as 1 month and 3 months post-intervention.